A serotonergic circuit controlling the circadian rhythm in Drosophila olfactory learning

The endogenous circadian clock modulates performance and cognitive function with rhythms in learning and
memory evident across species. In our modern workforce individuals work at adverse circadian times resulting
in impaired cognitive performance in these individuals, in addition to economic costs and public safety risks to
society. Furthermore, circadian desynchronization, a rising public health problem, increases the risk of
neurodegenerative diseases and cognitive impairments, which is projected to put a substantial economic burden
on our healthcare system as the population ages. Defining the molecular mechanisms through which the
circadian clock targets learning is crucial to identifying methods to not only prevent cognitive impairments but
to optimize performance and health in modern society. The ability to enhance learning and memory at non-
adaptive times of day would represent a significant advance in human health and performance. The long-term
goal of this project is to define the neural circuits and molecular signaling pathways used by the central circadian
oscillator to enforce a rhythm in olfactory learning in Drosophila melanogaster. Drosophila displays a robust
circadian rhythm in short-term memory formation. The identity and function of both central clock neurons and
olfactory learning circuits are well established in Drosophila, with many tools available to manipulate neuronal
activity with great specificity, making Drosophila an ideal model for this study. The central hypothesis is that the
endogenous circadian circuit modulates neurotransmission from the serotonergic DAL neurons to the
Mushroom Bodies, activating 5-HT1A receptors in the Mushroom Bodies, resulting in circadian rhythms in
learning. The rationale for the proposed research is that understanding an evolutionarily conserved mechanism
for the circadian control of memory acquisition can be used to understand learning modulation better and to
improve cognitive performance. This understanding will be developed with two specific aims: 1) Determine the
role of the Dorsal Anterior Lateral Neurons in controlling the circadian rhythm in olfactory learning. 2)
Determine if 5HT1A signaling in the α/β posterior neurons is required for the rhythm in olfactory learning. The
proposed experiments will elucidate how and where the clock circuit alters the learning circuit. The approach is
innovative because it focuses on improving cognitive performance by identifying mechanisms through which the
circadian clock regulates learning to produce time-of-day dependent decrements in performance and cognitive
function. The proposed research is significant because the neurocircuitry and molecular mechanism by which
endogenous clocks directly regulate learning are poorly understood in any system. The impact of time-of-day on
cognitive performance is widespread, and the consequences of out-of-phase performance can be devastating and
costly. Ultimately, understanding the logic underlying circadian control of memory formation will permit further
work to improve human health, alleviate some of the pressure on our healthcare system, and lower the economic
burden from neurodegenerative diseases and cognitive impairment.

Public health relevance
The proposed research is relevant to public health since circadian desynchronization is a rising public health problem leading to poor cognitive performance, increased accidents, and increased risk of neurodegenerative diseases. The project will detail a neural circuit and signaling pathway by which the endogenous circadian circuit directly modulates a well characterized learning circuit in Drosophila. The project is relevant to the mission of the NIH because an understanding of how the internal circadian clock modulates memory formation is required to address circadian desynchronization, and to alleviate some of the pressure on our healthcare system, and reduce the burden from neurodegenerative diseases and cognitive impairment.